Statistical methods for estimation of copy number from next-generation sequencing

DESCRIPTION (provided by applicant): This application addresses board Challenge Area (08) Genomics and specific challenge topic, 08-DA-102 Improved Bioinformatics Analysis for Deep Sequencing. The number of human samples undergoing whole-genome sequencing is expected to increase dramatically in the next few years, as advances in next-generation sequencing technologies continue to lower the cost of sequencing. In addition to detection of sequence variation, these data can be used to estimate DNA copy number variation and subsequently to examine correlation between copy number and phenotype. In this proposal, we aim to develop a series of computational steps and integrated analysis pipeline for accurate estimation of copy number from next-generation sequencing data. This involves efficient processing of the sequencing data, including appropriate alignment procedures and correction for experiment artifacts. For estimation of the copy number along chromosomal location, we will develop novel segmentation procedures, both for a single sample and for multiple samples, to take advantage of the specific nature of sequencing data. Importantly, we also address issues in experimental design, especially the effect of depth of sequencing (genome coverage) and read length on the resolution and accuracy of copy number profiles. We use data from a number of platforms including Solexa, SOLiD, and CompleteGenomes for our studies. The pipeline developed in this proposal will be implemented on a powerful distributed computing system and will be made available freely to the research community. The results of this project will thus enable efficient extraction of copy number from whole-genome sequencing data and will facilitate rapid translation of next-generation sequencing technology to identify structural variations associated with normal or disease phenotypes.

Public health relevance
PROJECT NARRATIVE ) A large number of prevalent diseases, most notably cancer, involve variations in DNA copy number. Thus, precise characterization of DNA copy number variations in both normal and diseased individuals is important for understanding their impact on human health and disease. Next- generation sequencing technology will be the major source of data for copy number variations in the coming years and the resources created in this project will enable researchers to obtain accurate copy number profiles from their experimental data. )